Obesity and Pancreatic Cancer Progression and Survival

PROJECT SUMMARY / ABSTRACT
The long-term career goal of the candidate, originally trained as a molecular biologist and now working in
cancer epidemiology research, is to become an independent investigator in molecular epidemiology of
pancreatic cancer. Pancreatic cancer is the third-leading cause of cancer death in the U.S., and is projected to
become the second leading cause by 2030. No population-based screening is available, and therapeutic
options are limited, resulting in a 5-year survival rate of only 8%. Identifying molecular mechanisms leading to
pancreatic cancer will create opportunities for targeted disease screening and new therapeutic strategies.
Obesity, a condition affecting more than 1/3 of the adult U.S. population, is associated with increased risk of
pancreatic cancer and with shorter patient survival; however the mechanisms behind these associations are
poorly understood. Building on her prior work, where she identified leptin signaling as one of the potential
mediators between obesity and pancreatic cancer, the candidate seeks to fill this knowledge gap by identifying
additional molecular pathways and alterations linking obesity and pancreatic cancer. The central hypothesis of
this proposal is that obesity alters oncogenic pathways in pancreatic tumor cells, promoting tumor growth and
progression. This hypothesis will be tested using several large patient populations with extensive
clinicopathological information, computed tomography (CT) imaging-based measurements of adipose tissues,
banked plasma samples, and genomically characterized pancreatic tumor specimens. Specifically, the
candidate proposes to: 1) characterize mechanisms linking prediagnostic obesity with shorter survival of
pancreatic cancer patients, 2) evaluate the role of obesity-associated adipokine signaling and inflammation in
cancer progression and patient survival, and 3) identify genetic signatures enriched in obesity-associated
pancreatic cancers. This comprehensive and interdisciplinary evaluation of obesity-associated systemic and
tumor tissue-based alterations will help identify pathways responsible for pancreatic cancer progression, with
important implications for disease screening and treatment. In order to accomplish those research aims, as
well as to attain her long-term career objective, the candidate requires further training in epidemiology,
biostatistics, and tumor genetics. This knowledge will be obtained through coursework at the Harvard T.H.
Chan School of Public Health, workshops, seminars, and participations in national meetings. She will be
mentored by an interdisciplinary advisory team composed of experts in epidemiology, biostatistics, molecular
pathology, cancer biology and genomics. This award will therefore provide the candidate with the knowledge
and expertise to accomplish her near-term research goals, while also providing career guidance that will allow
the candidate’s transition to an independent investigator in molecular epidemiology of pancreatic cancer.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is the third-leading cause of cancer related death in the U.S with a 5-year survival rate of only 8%. Although obesity is associated with increased risk of pancreatic cancer and shorter patient survival, the mechanisms underlying these associations are not known. We will comprehensively investigate systemic and molecular alterations associated with obesity in order to identify pathways involved in pancreatic cancer progression and worse patient outcomes.